Interdependence of Post-MI Local Revascularization and Remuscularization by Engineered Human Myocardium on Cardiac Remodeling and Regeneration

Project Summary/Abstract
Biomaterials enable the local, controlled delivery of therapeutics like proteins and cells to target tissues
damaged by injury or disease. Customization of these biomaterial-therapeutics systems is essential to
overcome challenges of specific microenvironments and achieve functional regeneration. The heart after
myocardial infarction (MI) is one such injury bed that necessitates localized treatments for re-establishing
microvessels and delivering new cardiomyocytes (CMs). The permanent decline in heart function in patients
post-MI is due to CM death and compromised perfusion, leading to the onset of heart failure in over 3 million
Americans. Persistent ischemia in the myocardium after acute MI limits the recovery and contractility of the
surviving heart muscle, and treatments have yet to replace the lost CMs. Attempts to deliver (a) angiogenic
growth factors to regenerate the vasculature and (b) new CMs derived from human induced pluripotent stem
cells (hiPSCs) to the post-MI heart have suffered from multiple challenges due to a lack of optimized delivery
systems. This project addresses this gap by advancing biomaterial systems for heart regeneration post-MI by
integrating a revascularization strategy for repair and a remuscularization strategy for regeneration. Our long-
term goal is to re-engineer contractility in the heart with a holistic approach to restore myocardium through the
vasculature and replenish CMs using engineered human myocardium (EHM). The overall objective of this
proposal is to demonstrate efficacy of customized biomaterials using an optimized angiogenic protein cocktail
and EHM to alleviate arrhythmia risk and improve contractility. These studies aim to understand how repair and
regeneration ensue by using longitudinal imaging to reveal dynamics of perfusion and contractility as well as
integrated 3D analyses of structure, perfusion, excitation, and contractility. Our central hypothesis is that
increasing perfused microvessel density in the infarct and EHM implant using local delivery of biomaterials for
microvascular regeneration and EHM for remuscularization will promote tissue preservation and maturation of
hiPSC-CMs to reduce arrhythmias and enhance contractility. We will rigorously test this hypothesis in two aims
with implantation of an angiogenic biomaterial film alone or with EHM in a rat model of ischemia/reperfusion
MI. Aim 1 is to evaluate how local controlled release of an angiogenic factor cocktail alters post-MI ventricular
remodeling, perfusion, arrhythmia risk, and contractility. Aim 2 is to elucidate how angiogenic co-therapy
modulates cellular remuscularization with EHM for post-MI regeneration of perfusion, excitation, and
contraction. The parallel aims develop our understanding of how biomaterials and tissue engineering advance
revascularization and remuscularization as effective angiogenic, anti-arrhythmic, and contractile therapies for
the heart. This project uses innovative technologies and analyses to accelerate novel treatments to the clinic
by revealing mechanistic insights into revascularization and remuscularization for heart repair and
regeneration.

Public health relevance
New biomaterials are revolutionizing how therapies are delivered to the body, yet these technologies have not been widely used for improving vessel growth and muscle function in patients who have suffered a heart attack. This project addresses this gap and many challenges in the heart by advancing customized vessel growth and muscle therapies using biomaterials with the goals of improving the blood supply in the heart, adding new heart muscle cells, and improving electrical and mechanical function of the heart. Experiments to help us understand how changes in heart function happen in response to these new biomaterial therapies will increase our understanding of the critical design features of the therapies to advance translation to the clinic for improving patient health and quality of life.